EPITOPE IMPRINTING OF GFP

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. We prepare several nanomaterials that target at the C-terminal of GFP. we would like to use FCS to detect the interaction between the GFP and nanomaterials.